Quadruple-resonance HFXY 1.3 mm CP-MAS probe for a solid-state NMR wide-bore magnet

Project Summary
This proposal aims to elucidate the structures and mechanism of action of three ion
channels and transporters of viruses and bacteria: the SARS-CoV-2 envelope (E) protein, the
influenza M2 protein, and the multidrug-resistant bacterial transporter, EmrE. All three proteins
form membrane-bound ion channels or transporters that are important for the lifecycle and
function of the respective virus or bacteria. Molecular structural information about these
membrane proteins forms the basis for designing antiviral and antibiotic compounds to prevent
viral and bacterial infections. For all three membrane proteins, fluorine has been strategically
incorporated into the proteins or the substrate to enable the measurement of nanometer distances
by solid-state NMR. These distances are powerful restraints for the interhelical assembly of these
membrane proteins and the protein-substrate binding-site structure. However, the current NMR
probe in the Hong lab for these 19F-based NMR experiments is limited by the spinning speed and
the availability of only one radiofrequency channel beside 1H and 19F. To obtain higher-resolution
NMR spectra and to correlate 1H and 19F signals with multiple nuclei, we request an 1.3 mm HFXY
probe that can spin samples to 65 kHz and that tunes to two heteronuclear channels (X and Y).
Using this 1.3 mm HFXY probe, we will investigate the open-state structure of the SARS-CoV-2
E protein, the open-state structure of an influenza BM2 mutant, and the substrate-binding site
geometry of the EmrE protein.

Public health relevance
Project narrative Elucidating the structures and dynamics of the SARS-CoV-2 envelope protein, the influenza B M2 protein, and the bacterial transporter EmrE, is highly significant for preventing future pandemics by these human-infecting pathogens. The requested 1.3 mm quadruple-resonance HFXY NMR probe will permit new cutting-edge NMR experiments to obtain structural information about these proteins in lipid membranes and as bound to small-molecule drugs.